Systematic Evaluation of the Application of Zebrafish in Toxicology (SEAZIT)

The goal of this project is to generate information on the current state of zebrafish testing and to conduct experiments to determine if NTP can optimize a zebrafish testing protocol. If this is able to occur, a multisite study to evaluate the consistency of response will be performed. Keywords: zebrafish, toxicity, alternative model